Deciphering inv3/t(3;3) Myeloid Leukemia Vulnerabilities via Proteogenomics and N-terminal Proteomics

PROJECT SUMMARY
The overall objective of this proposal is to develop and apply novel proteogenomic approaches to identify
therapeutic vulnerabilities of chromosome 3 rearranged myeloid leukemias. Chromosome 3 inversions or
transversions (inv3/t(3;3)) leukemias result in aberrant overexpression of oncogenic transcription factor MECOM
(MDS1 and EVI1 complex locus, specifically a truncated isoform EVI1) and decreased expression of tumor
suppressor GATA2. Inv3/t(3;3) abnormal myeloid leukemia patients have no targeted precision therapies as they
are resistant to standard of care regimens like Tyrosine Kinase Inhibitors (TKIs), and so experience dismal 5-
year survival rates of <5%. Consequently, there is an unmet need for new approaches to therapeutically target
inv3/t(3;3)-driven leukemias. Canonically, MECOM is critical in regulating hematopoiesis, however, alternative
transcripts of MECOM drive oncogenesis when overexpressed as a result of chromosomal rearrangements. In
addition to oncogenic MECOM, I hypothesize that the inv3/t(3;3) abnormality leads to the production of additional
leukemia specific proteoforms that contribute to the aggressive nature of this disease. Here, I will test this
hypothesis by comparing inv3/t(3;3) positive and negative myeloid leukemia cell lines with healthy cord-blood
derived hematopoietic progenitor cells using novel proteogenomic approaches. To test this hypothesis I will:
identify inv3/t(3;3) specific genes by combining RNA-Seq and bulk proteomics (Aim 1), utilize PacBio long read
sequencing with proteomics to identify novel protein coding alternative transcripts (Aim 2) and capture inv3/t(3;3)
unique post-translational processes through utilization of my N-terminal proteomics methodology termed N-
SPyCE (neo-N-terminal SP3 Pyridine Carboxaldehyde Enrichment) (Aim 3). In exciting preliminary data, I have
already identified several key candidates for MECOM-affected genes, including HLA-DPB1, IL16, SPP1, CD74
and ALDH1A1. Pathway analysis of my bulk proteomic data revealed a striking correlation between inv3/t(3;3)
harboring cells and increased cathepsin-mediated protease activity. I hypothesize that there are specific
cathepsin cleaved substrates that are specific effectors of inv3/t(3;3) biology. Overall, this project proposes to
utilize proteogenomics to detect disease specific transcript isoforms, to validate their expression at the protein
level and to investigate leukemia specific proteoforms as therapeutically relevant.

Public health relevance
PROJECT NARRATIVE Patients suffering from inv3/(3;3) myeloid leukemias experience low 5-year survival rates (<5%) as a result of a lack of targeted therapies and poor response to standard treatment regimens such as bone marrow transplant in combination with chemotherapy. This work will utilize innovative proteogenomic approaches to identify actionable targets for pharmacological studies and provide key mechanistic insights into the historically “undruggable” inv3/(t3;3) myeloid leukemia cancer cell biology. As a result of this work, I anticipate an addition to research on inv3/t(3;3) myeloid leukemias, with a long term impact of improving overall quality of and length of life for patients.